Administrative Core

The Hepatitis B HIV Cure Consortium (BICC) Administrative Core coordinates, facilitates, and integrates the three Cores (Shared Resources, Virology, Multiomics), Statistical and Data Management Center (SDMC), and three Projects to ensure the optimal scientific contribution of each component to understanding hepatitis B surface antigen (HBsAg) loss and decline in people with HIV (PWH). For all the Projects and Cores, the Administrative Core will perform those roles through enhancing communication within and between Cores and Projects, coordinating the sharing of human specimens and of cell culture resources, providing fiscal oversight, coordinating training opportunities for early-stage investigators (ESIs) and trainees, and providing a path for scientific and community input to BICC. The Administrative Core will sustain the BICC community and provide broad administrative leadership through the following Aims. Aim 1 will provide an organizational framework to optimize scientific discovery including outlining deliverables for sites. This aim will also facilitate communication through arranging regular meetings within and between the Cores and Projects. These meetings will include investigators from the domestic and international sites. It will also equitably distribute specimens among the Projects to maximize scientific knowledge about HBsAg dynamics. This aim will also host a website to disseminate information to the community to host a portal to share resources. The website will also host an intranet to facilitate standardization of protocols including housing standard operating procedures for BICC investigators. Aim 2 provides fiscal oversight to ensure operation within budget and reporting to the NIH for both domestic and international sites. Aim 3 provides oversight for adherence with human subjects and regulatory guidelines including biosafety and ensures that trainees and ESIs are trained in these areas. Aim 4 promotes training of ESIs and trainees through meetings that will identify specific training needs of these individuals. The Administrative Core will arrange for ESI travel to Johns Hopkins for the training or for a JHU investigator to travel to the site to provide training. Aim 5 is designed to integrate input from community and academic stakeholders through a community advisory board and a scientific advisory board. The Administrative Core will arrange regular meetings with these boards.